PORTING OF PSGVB ELECTRONIC STRUCTURE CODE TO SP2

The goal of this project is to complete the parallelization of the PSGVB electronic structure code on the IBM SP2. Considerable progress has been made in parallelizing the Hartree-Fock and LMP2 functionalities of PSGVB. Future work will involve improving efficiency and adding more functionalities such as the GVB, GVB-RCI, GVB-RCI-MP2, and DFT methodologies.